Trophoblast Differentiation

PROJECT SUMMARY/ABSTRACT
Hemochorial placentation occurs in many mammalian species including primates and rodents. It ensures the
most intimate contact between maternal and embryonic compartments and requires specialized adjustments.
Among these adjustments is the need for extensive remodeling of the maternal uterine spiral arteries. Uterine
vascular modifications are required for the delivery of nutrients to the fetus. Mechanisms controlling uterine
spiral artery remodeling remain poorly understood. Central to the vascular remodeling process is a specialized
population of trophoblast cells referred to as invasive trophoblast cells (generic term) or alternatively as
extravillous trophoblast (EVT) cells (human-specific term). Impairments in differentiation of the invasive
trophoblast/EVT cell lineage, intrauterine trophoblast cell invasion, and/or trophoblast cell-directed uterine cell
modulation contribute to early pregnancy loss, placental dysfunction, pregnancy-related diseases, and a range
of postnatal health issues. Our long-term goal is to elucidate regulatory processes controlling development of
the invasive trophoblast/EVT cell lineage and their role in establishing the uterine-placental interface.
Placentation in the human and rat are both characterized by deep intrauterine trophoblast cell invasion and
extensive trophoblast cell guided spiral artery remodeling. Our research strategy is based on our prior
establishment and extensive characterization of in vitro and in vivo models for studying deep hemochorial
placentation in the rat and the utilization of human placentation site specimens and human trophoblast stem
cells for investigating gene regulatory networks controlling EVT cell development. In this proposal we focus on
two regulatory pathways controlling invasive trophoblast/EVT cell differentiation: i) phosphatidylinositol 3-
kinase (PI3K)/AKT pathway; ii) CBP/EP300-interacting transactivator with Glu/Asp rich carboxy-terminal
domain 2 (CITED2)-regulated pathway. These regulatory pathways are viewed as entry points and guides to
mechanisms controlling development of the invasive trophoblast/EVT cell lineage. The proposed research
provides an innovative approach to studying deep hemochorial placentation. Collectively, the research is
directed toward elucidating molecular mechanisms underlying physiologically relevant processes that ensure
successful hemochorial placentation. This approach will lead to the identification of conserved regulatory
pathways controlling the invasive trophoblast/EVT cell lineage, which will create opportunities and a platform for
understanding the pathogenesis of placental anomalies leading to pregnancy disorders.

Public health relevance
PROJECT NARRATIVE/RELEVANCE STATEMENT Disorders of hemochorial placentation are a significant human health issue. There is a paucity of knowledge regarding the regulation of trophoblast stem cells, their differentiation into invasive/extravillous trophoblast cells that effectively invade into the uterus and restructure uterine spiral arteries and establish the uterine-placental interface. Experimental dissection of fundamental mechanisms underlying the derivation of the invasive/extravillous trophoblast cell lineage is a key to understanding the etiology of placentation-related diseases and a necessity for establishing appropriate and efficacious diagnostic and therapeutic strategies.